Synthetic epigenetic circuits: tunable cell fate switches controlled by dynamic and combinatorial inputs

PROJECT SUMMARY
Cellular differentiation is controlled by epigenetic regulatory systems that integrate multiple sensory inputs over
time to direct long-term cell fate decisions. Harnessing epigenetic regulation in the design of synthetic gene
circuits would greatly augment synthetic biology. Synthetic epigenetic circuits based on controlling chromatin
state present many attractive advantages over current forms of artificial cellular memory (e.g. recombinase or
Cas9-based switches/cascades) which can be limited in scalability, stability, and temporal control. Natural
epigenetic systems support stable memory states without altering genetic information, can induce state changes
in either deterministic or stochastic fashion, and still maintain reversibility.
We propose to generate a synthetic toolbox to regulate chromatin state in response to user-specified inputs,
thereby allowing construction of circuits with key epigenetic properties, such as memory, fate bifurcation and
temporally controlled gene expression. Our proposed circuits will be designed to a) respond to a variety of
extracellular input cues through synthetic Notch receptors, b) discriminate inputs by duration to specifically
induce cell fate changes only in response to persistent environmental stimuli, c) temporally control gene
expression programs to promote sequences of cellular behaviors, and finally d) establish divergent
differentiation states to allow functionally advantageous specialization within a cell population. Our work will
be developed in the testbed of CAR T cell immunotherapy, a major application area for mammalian cellular
engineering that could greatly benefit from synthetic circuits that incorporate epigenetic memory and temporal
control capabilities. The resulting epigenetic toolkit and circuits, however, will be applicable to a much larger
range of engineered cells, including applications in regenerative medicine and cell therapies more broadly.

Public health relevance
PROJECT NARRATIVE Harnessing epigenetic regulation into Synthetic Biology has the potential of augmenting the scope of cellular engineering with the functional capabilities of that support natural development, such as integration of multiple signals over time to support cellular fate decisions that are stably inherited and the execution of temporally controlled gene expression programs. To address this need, the proposed research aims will establish a versatile circuit design platform that leverages epigenetic regulation to elicit memory and temporally regulated expression programming in mammalian cells, such as cellular timers to orchestrate gene expression sequences, recorders for monitoring and appropriately responding to disease in the host and artificial cell differentiation to drive cells to adopt distinct and complementary functional roles. These capabilities will be critical for engineering novel cell therapies to effectively tackle complex diseases and address future therapeutic challenges.